Inhibitors of TrkB Signaling

Abstract
Temporal lobe epilepsy (TLE) is a common and often devastating form of human epilepsy that currently
lacks preventive or disease modifying therapy. Evidence from clinical and preclinical studies supports the idea
that an episode of prolonged seizures (status epilepticus or SE) contributes to development of TLE. Defining
the molecular mechanisms by which SE transforms a normal brain into an epileptic brain can identify molecular
targets for preventive therapies. We conducted an extensive series of target validation experiments and
identified a druggable molecular target that can prevent TLE in mice, namely the brain-derived neurotrophic
factor receptor tyrosine kinase, TrkB. We conducted a high-throughput screen seeking small molecule
inhibitors and have identified two broad chemotypes, each of which contains multiple chemical series. Here
we seek to enter the Discovery stage of the Blueprint Network during which we will prosecute a medicinal
chemistry effort to improve the potency and drug-like properties of promising bioactive compounds. We
propose the following Aims. Aim 1: To complete preparation for entering UH3 phase. Aim 2 (UH3 phase): To
prosecute an SAR lead optimization effort to identify a clinical candidate molecule. Aim 3 (UH3 Phase): To
conduct IND enabling studies. The lack of effective preventive and disease modifying therapies for common
disorders of the human nervous system is a glaring unmet medical need critical to the mission of NINDS. The
work proposed here represents a novel and innovative approach to develop drugs for prevention and disease
modification of TLE, a common disorder of the CNS.

Public health relevance
Project Narrative Lack of effective preventive or disease modifying therapies for common disorders of the human nervous system is a glaring unmet medical need critical to the mission of NINDS. The work proposed here seeks to develop a small molecule inhibitor of TrkB signaling for advance to the clinic. Success of this project may pave the way to preventive and/or disease modifying therapies of temporal lobe epilepsy, a common disorder of the human nervous system.